LpxH Inhibitors as Novel Therapeutics Against Multidrug-resistant Enterobacterales

Project Summary/Abstract
An alarming number of Gram-negative nosocomial pathogens have acquired resistance to nearly all currently
available antibiotics, making it very difficult to treat patients effectively. Although a handful of new antimicrobial
agents have been approved by the FDA recently, they have mostly targeted drug-resistant Gram-positive
pathogens. Thus, new antibiotics targeting unexploited pathways are desperately needed to stem the tide of
multidrug-resistant Gram-negative bacteria that are becoming a major threat to the public health. The goal of
this proposal is to develop small molecule inhibitors of LpxH, an essential enzyme in the lipid A biosynthetic
pathway, as novel antibiotics for the treatment of Gram-negative bacterial infections caused by multidrug-
resistant Enterobacterales, such as the extended-spectrum -lactamase (ESBL)-producing Enterobacterales
and carbapenem-resistant Enterobacterales (CREs), that pose serious threats to the public health. Preliminary
data have demonstrated our expertise in developing and optimizing small molecule inhibitors of LpxH based on
structural insights and ligand dynamics information and have established the in vivo efficacy of a promising new
LpxH inhibitor in rescuing mice with lethal Klebsiella pneumoniae infection. Leveraging our accumulated
knowledge and demonstrable success in LpxH inhibitor development, we propose to design and synthesize
potent LpxH inhibitors with optimal drug-like properties. At the completion of the project, we anticipate having
developed a lead LpxH inhibitor with potent antibiotic activity against multidrug-resistant Enterobacterales (such
as E. coli and K. pneumoniae) and having demonstrated its safety and efficacy in the murine sepsis model. The
successful execution of the proposed studies will establish the therapeutic potential of LpxH-targeting antibiotics
and set the stage for accelerated clinical development.

Public health relevance
Project Narrative (Public Health Relevance Statement) The wide spread of multidrug-resistant Gram-negative pathogens, including the extended-spectrum -lactamase (ESBL)-producing Enterobacterales and carbapenem-resistant Enterobacterales (CREs), is a major threat to the public health. We propose to develop novel inhibitors of LpxH involved in the biosynthesis of lipid A, an essential component of the outer surface of Gram-negative bacteria, as effective antibiotics against clinically important multidrug-resistant Enterobacterales. Since no commercial antibiotics currently target this pathway, LpxH inhibitors should be refractory to existing compound-specific resistance mechanisms, thus presenting a clear advantage over the continuing development of antibiotics against established targets.